Craniofacial microsomia: Accelerating Research and Education (CARE)

Project Summary/Abstract
Craniofacial microsomia (CFM) is the third most common congenital craniofacial condition and typically
involves underdevelopment of the facial structures, including the ear (e.g., microtia) and jaw (e.g., mandibular
hypoplasia). Individuals with CFM have complex healthcare needs and frequently require a coordinated
evaluations and interventions to optimize hearing, neurodevelopment, breathing, and minimize the impact of
extra-cranial malformations. We have established an international community of individuals affected by CFM,
healthcare providers, and advocacy leaders to facilitate research in CFM. We are currently conducting a large,
international study in which we are exploring the lived experiences of individuals with CFM and exploring the
healthcare and psychosocial experiences of this population. We are collecting multi-perspective data from
English and Spanish speaking individuals with CFM and their caregivers across the treatment pathway.
Early in 2023, NIH introduced new data sharing requirements for NIH-funded studies. Data sharing allows
investigators to maximize the usefulness of existing data to answer important research questions. However, we
lack information from the craniofacial community regarding stakeholder preferences about sharing of clinical
phenotypic data used for research. This is an important issue especially for participants with rare and visible
conditions. From an ethical perspective, it’s critical to develop guidelines that reflect participants lived
experiences and values. To our knowledge, this has not been done in individuals with craniofacial conditions
for sharing of phenotypic data. We propose to advance knowledge regarding data sharing in clinical
craniofacial research by addressing the following specific aims: Aim 1. Explore patient and caregiver
perspectives on research data sharing for craniofacial research. Aim 2. Synthesize empirical data and ethical
norms to produce recommendations for data sharing in patient-oriented craniofacial research. As part of this
proposal, we have established a CARE Ethics of Data Sharing Committee composed of multiple stakeholders,
and this group will produce a manuscript addressing considerations for data sharing for patient-oriented
craniofacial research. This bioethics research proposal will add to the existing evidence base regarding
participant preferences for data sharing in individuals with visible conditions.

Public health relevance
PROJECT NARRATIVE We propose to expand the scope of an existing research collaboration with individuals with craniofacial microsomia, their caregivers, craniofacial healthcare providers, and advocacy group leaders to evaluate the psychological health status and healthcare experiences of individuals with CFM and their caregivers. In the parent grant, we are gathering many different types of data from research participants in order to better understand healthcare histories and identify opportunities for improvement in care for children with craniofacial microsomia. In this project, we propose to conduct in-depth interviews with members of the CFM community to learn more about their perspectives on clinical research and sharing data and incorporate their perspectives into data sharing guidelines.